Stitch-seq for genome-wide pooled genomic screening with RNA-seq readout

PROJECT SUMMARY
Large-scale pooled CRISPR screens have proven to be a powerful approach to identify genes that affect cell
state and behavior. Notwithstanding the countless genetic associations discovered with proliferation and drug
resistance pathways using viability or marker-based enrichment screens, there is tremendous potential for
pooled screens to go further by incorporating high complexity readouts like gene expression profiles. The cancer
community is already acting on this opportunity to access new pathways and immediately gain mechanistic
information about the nature of screening hits by interpreting the impact of perturbations on expression profiles.
However, pooled gene expression screens are underutilized and not routinely applied for large (eg. genome-
wide) screens for a simple reason - the cost of processing so many cells for single-cell gene expression readout
and carrying out the massive amount of sequence data generation required is too high.
Here, we propose to solve this problem with a method we call Stitch-seq, an ultra-high-throughput droplet-based
overlap PCR method that enables readout of the expression levels of a target gene panel in the pooled screening
context. Stitch-seq is low-cost because it does not require specialized barcoded reagents like beads and
operates as a massively parallel single-cell emulsion Rt-PCR that physically links CRISPR guide RNA
sequences to the targeted mRNA sequences by overlap extension. In the proposed work, we will characterize
the quantitative performance of the Stitch-seq reaction in detail, and demonstrate the technical and cost
performance of Stitch-seq in targeted and genome-wide screens. Stitch-seq will address the significant
throughput limitations associated with existing pooled CRISPR expression screening modalities by providing a
facile, low-cost, and ultra-high-throughput method to physically link perturbations to gene sets of interest across
a range of perturbation modalities including all manner of CRISPR perturbations (knock-out, CRISPRi,
CRISPRoff, CRISPRa, base editing, prime editing, etc.) and beyond.

Public health relevance
NARRATIVE Genetic screens teach us how genetic elements in our bodies’ cells relate to normal health, disease, and the way drug therapies work. Recently, powerful genetic screening technologies producing rich data about the internal state of cells have been developed, but they are expensive and can only be used to study a handful of genetic elements at a time. Here, we propose to develop and demonstrate a method that can test tens of thousands of genetic elements at once by focusing on only a select few key aspects of the cell state.